Characterizing heterochromatin dysfunction as a driving alteration in cancer

PROJECT SUMMARY
Recent research has emphatically confirmed that cancer is characterized not only by mutations in genes, but
also by disturbances in gene regulation. This latter mechanism often involves chromatin—the proteins and
regulatory molecules directly associated with DNA—and their influence on gene expression through so-called
“epigenetic” effects. Inactivation of the chromatin regulator protein ATRX (-thalassemia mental retardation X-
linked) is commonly seen in several cancer variants, including malignant glioma, the most common and deadly
primary brain cancer. While ATRX has been implicated in a variety of biological processes in normal cells, its
role in cancer biology is less clear. In our recent work, we confirmed that ATRX deficiency dramatically alters
chromatin and underlying gene expression, while also rendering DNA more susceptible to damage, breakage,
and other abnormalities. In particular, we found that ATRX loss disrupts the organization of specific regions of
chromatin, called heterochromatin, where key developmental genes undergo systematic silencing as organ
systems mature. Prior work by other groups suggests that heterochromatin dysfunction, and loss of underlying
gene silencing, contributes to cancer development. The central hypothesis of our proposal is that disruptions
in heterochromatin promote glioma formation by altering gene expression and inducing damage and
abnormalities in DNA. In this project, we will address our central hypothesis using customized human and
mouse cell lines that recapitulate the core biological and molecular features of ATRX-deficient glioma, along
with bona fide glioma cell lines, with and without ATRX deficiency, derived directly from patients. Some of our
studies will incorporate glioma models in mice. Furnished with these reagents, we will conduct epigenetic
profiling, coupled with microscopy and molecular and cell biological approaches, to correlate chromatin-related
findings with cancerous behaviors. In our first aim, we will characterize the mechanisms by which ATRX
deficiency alters heterochromatin in glioma. In our second aim, we will delineate the extent to which
heterochromatin dysfunction in ATRX-deficient glioma promotes damage and abnormalities in DNA. Finally, in
our third aim, we will identify key gene expression changes associated with ATRX deficiency that drive
cancerous behavior in glioma and investigate mechanisms by which they can be therapeutically targeted. If
successful, our work will characterize an entirely novel molecular process driving cancer formation and provide
insights into treatment strategies for deadly brain tumors.

Public health relevance
PROJECT NARRATIVE Inactivating mutations in the chromatin regulator gene ATRX have been identified in several cancers, often at high rates. This project will characterize the mechanisms by which ATRX loss drives the formation of gliomas, the most common and deadly primary brain cancers. In particular, we will examine how changes in the organization of DNA in regions called heterochromatin mediate the effects of ATRX inactivation in glioma.